Progressive seizure-induced cardiorespiratory dysfunction in a novel mutant rat model of seizure disorder

Project Summary
More than 50 million people suffer from epilepsy globally. Current anti-epileptic drugs (AEDs) cannot prevent
seizures in ~30% of these patients, leading to uncontrolled or refractory epilepsy. Unfortunately, these patients
are at extreme risk of Sudden Unexpected Death in Epilepsy (SUDEP), which is the leading cause of death in
this cohort. Based on landmark SUDEP studies, the current hypothesis is that recurrent seizures induce extreme
cardiorespiratory suppression and/or failure through negative effects on the neural networks that regulate vital
functions such as breathing, heart rate and blood pressure. However, it remains unclear how repeated seizures
fundamentally affect cardiorespiratory control networks within the brainstem, and by what mechanisms these
vital systems fail in SUDEP. Here we aim to characterize the pathophysiologic consequences of repeated
seizures in a novel rat model with a known mutation in a potassium channel gene (kcnj16; SSkcnj16-/- rats), in
which a specific sound of mild intensity readily and reproducibly causes generalized tonic-clonic seizures
(GTCSs). Sound-induced GTCSs in SSkcnj16-/- rats led to a stereotypic pattern of events similar to that described
in epilepsy patients, including post-ictal generalized EEG suppression and apnea, followed by respiratory rate
(RR) and heart rate (HR) suppression. Repeated seizures (1/day for up to 10 days) led to: 1) augmented post-
ictal suppression of RR and HR, reduced ventilatory responses to hypoxic and hypercapnic challenges, and
unexpected mortality in ~33% of these rats. Brainstem tissue analyses of SSkcnj16-/- rats exposed to repeated
seizures showed evidence of time-dependent increases in inflammation and dysregulation of adenosine (ADO)
and serotonin (5-HT) – two powerful modulators of cardiorespiratory neural networks. Finally, pharmacologically
augmenting 5-HT with an SSRI (fluoxetine) prevented the progressive suppression of post-ictal RR with repeated
seizures. Herein we will test our central hypothesis that repeated seizures cause a progressive brainstem
pathology initiated by neuroinflammation and mediated by ADO and 5-HT dysfunction leading to
cardiorespiratory suppression and/or failure in SUDEP. The proposed studies utilizing this novel mutant rat
model will provide: 1) a comprehensive characterization of the progressive pathophysiological responses to
repeated audiogenic seizures, and sequence of events leading to unexpected death (Aim 1), 2) identified
mechanisms of dysfunction in inflammatory and/or neuromodulatory pathways within critical cardiorespiratory
brainstem nuclei negatively affected by repeated seizures (Aim 2), and 3) interventions that functionally test our
hypothesis by blocking neuroinflammation or modulating ADO or 5-HT system activity on the backdrop of
repeated seizures (Aim 3). We will utilize a combination of established and cutting-edge technologies to provide
unprecedented molecular, cellular and systems-level insights into the pathophysiological consequences
repeated seizures on vital control systems in order to identify novel targets for therapeutic interventions aimed
at preventing or mitigating the risk of SUDEP in human epilepsy patients.

Public health relevance
Project Narrative About one-third of patients afflicted with epilepsy have repeated seizures, which dramatically increases the risk of unexpected seizure-related death (SUDEP) thought to occur due to suppression of breathing and heart rate. Here, we will characterize the negative consequences of repeated seizures on breathing and heart rate, pathological changes within brainstem regions critical for regulating these functions, and test interventions that may improve outcomes in a unique mutant rat with sound-induced seizures. Completion of these proposed studies will identify molecular pathways leading to cardiorespiratory dysfunction/failure in rats in order to develop new therapies in human epilepsy patients to prevent or reduced the risk of SUDEP.